CORE--BIOMEDICAL COMPUTING

For fifteen years the Biomedical Computing Shared Resource (BCSR) has promoted high quality innovate cancer research by providing members of the UWCCC with an advanced biomedical computing environment. As a matter of policy, computing support within the University and Medical School is decentralized and largely the responsibility of individual departments and centers such as the UWCCC. Within this context, the BCSR plays an essential role by providing both technical and intellectual resources that address the unique and specific needs of the UWCCC in an efficient and cost effective manner. The BCSR supports the UWCCC research enterprise in five years. First, it is responsible for much of the network and I/T infrastructure used on a daily basis by every connected UWCCC member. Second, it provides an array of computing services to UWCCC investigators, other shared resources, and to UWCCC administration. Third, it develops and maintains specialized research resources targeted to the particular needs of UWCCC investigators. Fourth, BCSR staff provide critical software engineering, project management and computer science expertise for specific projects. Fifth, the staff of the BCSR fulfill an important leadership role by tracking or anticipating the needs of the UWCCC research community and then developing the resources to meet these needs. The facilities of the BCSR have been used by Drs. Gould, Moser and Newton to build genetic maps of mice and rats. Drs. Newton and Reznikoff have used them to test new methods for assessing gene loss. Drs. Lindstrom and Kinsella have used these facilities to assess models for therapeutic radiation damage to tumors. Drs. Love and Sondel have used these facilities to build and maintain research databases. In addition, the facilities and staff of the BCSR are used by scientific-oriented shared resources such as the Clinical Trials Research Office for patient and protocol tracking, the Analytical Instrumentation Laboratory and Flow Cytometry for computing support and consultation, and the Biostatistics Shared Resource for computational and database resources. The BCSR also provides essential support and services to UWCCC Administration.